Project 6 - PKC Iota

PROJECT SUMMARY ? Project 6 Ovarian cancer remains the deadliest gynecological cancer, underscoring the need for better treatment options. Our published work demonstrates that PKCι, a PKC isoform not targeted by PKC inhibitors previously tested in the clinic, is an oncogene in ovarian and non-small cell lung cancer (NSCLC), where it plays critical roles in tumor initiation and progression. PKCι is also genetically activated in the most common serous ovarian tumor subtype: ~80% of high grade serous ovarian tumors exhibit PRKCI copy number gains associated with elevated PKCι expression. Interestingly, our published and preliminary data demonstrate that PKCι drives tumorigenesis in the ovary by a distinct, novel mechanism not observed in other tumors. Specifically, our preliminary studies indicate that: 1) ovarian cancer cells are “addicted” to PKCι such that genetic or pharmacologic inhibition of PKCι leads to loss of ovarian cell growth and viability; 2) PKCι maintains a chemoresistant phenotype in ovarian cancer cells characterized by stem-like behavior, enhanced resistance to cisplatin and enhanced tumorigenicity; 3) PKCι activates a novel oncogenic PKCι- SOX2-HIPPO/YAP1 signaling pathway in these chemoresistant tumor-initiating cells (TICs); and 4) a novel small molecule PKCι inhibitor developed in collaboration with a pharmaceutical partner inhibits proliferation and viability of both bulk tumor cells and chemoresistant TICs. Based on these data we hypothesize that: 1) PKCι maintains a chemoresistant phenotype, in part, through activation of HIPPO/YAP1 signaling; 2) a novel PKCι inhibitor will effectively inhibit this pathway and block ovarian cancer cell transformed growth; 3) high grade serous ovarian cancers harboring PRKCI amplification and PKCι overexpression are “addicted” to PKCι and will, therefore, be more responsive to PKCι inhibition than tumors without this genetic characteristic; 4) components of oncogenic PKCι-SOX2- HIPPO/YAP1 signaling can be developed as pharmacodynamic biomarkers of PKCι inhibition and possible predictive biomarkers of ovarian cancer sensitivity to PKCι inhibitor therapy; 5) a highly potent and specific PKCι inhibitor will effectively inhibit tumor PKCι and exhibit anti-tumor activity in a first-in-human therapeutic trial. These hypotheses will be tested through completion of three interrelated specific aims to: 1) dissect the mechanism by which PKCι regulates chemoresistant ovarian cancer cell behavior and assess the effect of PKCι inhibition on these cells; 2) assess the effect of PKCι inhibitor on primary serous ovarian cancer growth and validate biomarkers of response to PKCι inhibition using well validated patient-derived xenograft models; and 3) assess the ability of a highly potent and specific PKCι inhibitor to inhibit PKCι clinically in a first-in-human phase I clinical trial. Collectively, these studies will provide the first rigorous test of the hypothesis that PKCι can be targeted for therapeutic benefit in ovarian cancer.

Public health relevance
Narrative Protein Kinase Cι is an oncogene that is overexpressed in the majority (~70-80%) of high grade serous ovarian cancers as a result of tumor-specific gene amplification. PKCι plays a critical role in the establishment and maintenance of a chemoresistant, tumor-initiating phenotype in ovarian cancer cells. This application proposes to identify the specific signaling pathways by which PKCι drives ovarian cancer cell growth, identify tumor biomarkers of PKCι signaling, and conduct a first-in-human phase I clinical trial of a novel PKCι inhibitor as a new approach to treating ovarian cancer.